Technology for ten-minute resolution protein interaction mapping at proteome scale

Project Summary Genes mediate their effects through networks of macromolecular interactions. Large-scale studies have mapped protein interactions for humans and several model organisms. However, even for S. cerevisiae, the most intensively-studied eukaryotic model, knowledge of the protein interaction network remains both incomplete and “static”, in the sense that each global interaction mapping study has used essentially the same growth environment and genetic background. Moreover, despite the many known examples of signalling interactions that appear and fade rapidly after an environmental stress, large-scale interaction maps represent the time- average of interaction over many generations of a cell. We previously extended the yeast two-hybrid (Y2H) interaction assay with a “barcode fusion genetics” (BFG) strategy, which uses intracellular recombination to form chimeric barcodes that identify bait/prey protein combinations. This “BFG-Y2H” method enabled multiplexing of millions of interaction assays, with internal biological replication, all within a single en masse experiment, and has already been used for proteome-scale mapping of yeast interactions under four growth environments. Here we propose a further extension, in which the promoter that traditionally reports on interaction status is used to transcribe the chimeric bait/prey barcode locus. Sequencing these “interaction tags” can thus provide a quantitative measure of promoter output. Importantly, the rapid dynamics of transcript production and degradation have the potential to enable measurement of interaction dynamics with ~10-minute time resolution, at proteome scale, in living cells.

Public health relevance
Narrative Cells respond dynamically to environmental change and undergo major changes as they grow and divide. This is accomplished in part through disruption and formation of specific interactions between proteins. However, our knowledge of protein interactions remains largely incomplete for humans and all model organisms. Because interactions change dynamically between environments, we propose to develop a new strategy with a potential to map rapid changes in protein interactions after an environmental challenge, and to discover even those interactions that appear only fleetingly after an abrupt environmental shift. Although we will apply our strategy only for a single protein interaction detection assay within a yeast model of the eukaryotic cell, the more general concept we propose could potentially be adapted to other interaction assays within human and other cell-based models.